Human Milk Preservation and Pasteurization using Rapid Thermal Control of Liquids

PROJECT SUMMARY
Human milk (HM) provides the critical nutritional composition and non-nutritive bioactive factors that promote the
healthy development of infants. HM is often stored by refrigeration or freezing and then thawed and/or warmed
to body temperature (37 oC) prior to serving. Additionally, HM provided by a milk bank is required to undergo
pasteurization. All these processes create opportunities for degradation of vital HM components that can reduce
its value for the health and growth of babies. Although there have been studies considering the impact of
processing on certain HM components, conditions and conclusions vary widely. We will execute a rigorously
controlled and comprehensive analysis of the response of a wide array of HM components to standard
pasteurization protocols, freeze/thaw methods, and rewarming approaches. This is significant because it will
provide clear guidance on HM handling of this entire process to maximize preservation of important milk
components. Another innovation of the proposal is that it will characterize effectiveness of our unique Rapid
Thermal Control of Liquids (RealCooL) platform technology invented by our group to control temperature and
preserve HM components. RealCooL is capable of more spatially-uniform temperature, 20-fold increased cooling
rate, and 18-fold increased heating rate compared to conventional methods of thermal processing. We
hypothesize that current processing methods cause degradation of HM components and that RealCooL will
enhance preservation of HM. To test our hypothesis, we will execute the following specific aims. Aim 1:
Determine the effect of standard thermal processing methods on HM composition. This aim provides a
comprehensive and standardized assessment of the impact of thermal processing methods by commercially-
available devices (refrigerator, freezer, pasteurizer, and bottle warmer) on selected HM components. We will
measure somatic cell count, lactoferrin, lysozyme, lipase, sIgA, IgM, IgG, interleukins, and bacteria in raw milk
and milk that has undergone a range of heating and cooling processing characteristic of procedures used at
home, milk banks, hospital nurseries, and daycares. The impact of individual and combined processes will be
documented. Aim 2: Determine the effect of RealCooL thermal processing methods on HM composition.
This aim will evaluate our innovative RealCooL system that rapidly and precisely pasteurizes, thaws, cools, and
rewarms milk by directly warming and cooling it using a heat exchanger with a novel control system. We will
evaluate its capability to execute desired processing of HM with a single device compared to separate traditional
devices used in Aim 1. This project is impactful because knowledge gained will include the potential degradation
of HM components for both standard thermal processing methods as well as the novel RealCooL system. Results
will guide the development of improved devices and processing standards to optimize the quality of HM that is
provided to babies, ensuring they receive maximum value which should result in better nutrition and growth.

Public health relevance
PROJECT NARRATIVE Although there have been studies considering the impact of thermal processing on certain human milk components, conditions and conclusions vary widely. We will execute a rigorously controlled and comprehensive analysis of the response of an array of human milk components to standard pasteurization protocols, freeze/thaw methods, and rewarming approaches using both conventional devices and our novel Rapid Thermal Control of Liquids (RealCooL) platform technology. Our results will guide the development of improved devices and processing standards to optimize quality of human milk that is provided to babies, ensuring they receive maximum value which should result in better nutrition and growth.